Clinical Translation Core - RC3

Resource Core 3 (RC3) Clinical Translation Core: Project Summary
The Johns Hopkins University (JHU) Older Americans Independence Center (OAIC) proposes to offer a
resource core entitled Clinical Translation Core, or Resource Core 3 (RC3). This core—now in its 10th year—
was designed to accelerate the translation of important biological findings related to frailty into clinical studies,
and because of the need to train and support junior investigators proposing clinical investigations in frail, older
adults. This initiative is closely aligned with the JHU Division of Geriatric Medicine and Gerontology's goals of
integrating frailty-related research into clinical practice. The specific aims of RC3 are 1) to provide supported
OAIC investigators with comprehensive training, mentorship and access to expertise in clinical research, 2) to
provide the oversight necessary to ensure optimal and safe performance of clinical studies, 3) to provide
clinical research space and assistance with all aspects of protocol development, data collection, and
recruitment of human subjects as needed, and 4) to maintain and further develop an active registry of older
adults characterized for frailty and consented to be contacted for additional aging and frailty related studies. A
core leader with substantial clinical research expertise in aging and HIV-related metabolic studies, and who
also leads a core and infrastructure in the JHU Institute of Clinical and Translational Research (ICTR), will
facilitate the development, implementation, and conduct of both clinical physiological studies and clinical trials
in this core. A highly skilled and experienced research program manager with expertise in recruitment of
minoritized older adults and in the measurement of frailty and mobility, along with a team of experienced
recruiters, will facilitate completion of Core aims. These aims will be carried out in close collaboration with the
leaders of all other resource cores. Additional resources are provided by the ICTR, which will help ensure
optimal study design, implementation, and interpretation of results, and Fast Forward, a translationally-focused
unit at JHU will facilitate health technology development. This core will play a crucial role in the training of
junior investigators engaged in Research Education Component (REC) activities and in pilot/exploratory
studies, conduct developmental research as needed and will newly engage community advisory boards to
maximize research relevance and potential to increase health equity. RC3 will continue to accelerate the pace
of translation of the important biological findings being generated in this OAIC into frailty-related clinical studies
that promote the maintenance of independence in older adults.